Does repeated influenza vaccination constrain influenza immune responses and protection?

PROJECT SUMMARY/ABSTRACT
Over 140 million Americans are among the more than 500 million people who receive influenza vaccines an-
nually. An important subgroup are healthcare workers (HCWs) for whom vaccination is recommended, and
sometimes mandated, to protect themselves and vulnerable patients from influenza infection. However, there
have been no large, long term studies of HCWs to support the effectiveness of these policies. HCWs are now a
highly vaccinated population, the effects of which are also poorly understood. Mounting evidence suggests an-
tibody responses to vaccination can be attenuated with repeated vaccination, which is corroborated by reports
of poor vaccine effectiveness among the repeatedly vaccinated. Thus, there is a compelling need to directly
evaluate HCW vaccination programs. The long term goal is to improve the efficient and effective use of influ-
enza vaccines. The objectives of this application are to understand the long-term consequences of repeated
annual influenza vaccination among HCWs and to use statistical and mathematical modeling to elucidate the
immunological processes that underlie vaccination responses and their implications for vaccination effective-
ness. These objectives will be achieved by pursuing three specific aims: 1) To study the immunogenicity and
effectiveness of influenza vaccination by prior vaccination experience; 2) To characterize immunological pro-
files associated with vaccination and infection; and 3) To evaluate the impact of immunity on vaccination effec-
tiveness. Under Aim 1, a cohort of hospital workers will be recruited and followed for up to 4 years to assess
their pre- and post-vaccination and post-season antibody responses, and their risk of influenza infection. These
outcomes will be compared by vaccination experience, classified as frequently vaccinated (received ≥3 vac-
cines in the past 5 years), infrequently vaccinated (<3 vaccinations in past 5 years), vaccinated once, vaccine-
naïve and unvaccinated. In Aim 2, intensive cellular and serological assessments will be conducted to dissect
the influenza HA-reactive B cell and antibody response, and build antibody landscapes that typify the different
vaccination groups. In Aim 3, the data generated in Aims 1 and 2 will be used to develop a mathematical mod-
el that considers prior infection, vaccination history, antibody kinetics, and antigenic distance to understand the
effects of repeated vaccination on vaccine effectiveness. This approach is innovative because it will provide
insights into the effect of complex immunological dynamics on infection outcomes, thereby representing a nov-
el departure from previous studies, which have ignored these difficult-to-measure processes. Completion of the
proposed research will provide evidence to inform decisions about continued support for influenza vaccination
programs among HCWs and general policies for annual influenza vaccination, as well as much-needed clarity
about the effects of repeated vaccination.

Public health relevance
NARRATIVE The proposed research, to understand the potentially negative consequences of repeated influenza vaccina- tion, is relevant to public health because influenza vaccines are widely employed as a key strategy to reduce the considerable burden of influenza. By developing a better understanding of the immunologic mechanisms underlying vaccine-induced responses, it will be possible to explain – an potentially enhance – vaccine immu- nogenicity and, hence, effectiveness. Thus, the proposed research is relevant to the part of NIH’s mission to foster innovative research strategies and their applications as a basis for ultimately protecting and improving health.